Development of Monoclonal Antibodies for the Study of Mycobacterium tuberculosis (Mtb) in the Guinea Pig

GlycoScientific proposes to generate antibodies specific for six inflammatory cytokines to elucidate and correlate immunological markers of tuberculosis (TB) transmission and disease development in the guinea pig. Once the antibodies are produced, the Offeror will use them to evaluate the cytokines in TB infected and non-infected guinea pigs. The production of these crucial immunological reagents will greatly enhance our understanding of basic immune responses to TB infection in naturally infected mammalian models.